Plan to Enhance Diversity

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
PLAN TO ENHANCE DIVERSITY - PROJECT SUMMARY/ABSTRACT
The Montefiore Einstein Cancer Center’s overarching mission is to become a national model for reducing cancer
incidence and disparities in the most diverse and impoverished catchment area of all NCI-designated cancer
centers in the U.S. Our Plan to Enhance Diversity will ensure that all groups that are underrepresented in the
cancer workforce, including individuals from very different demographic, racial, ethnic, religious, gender and
sexual orientation backgrounds, etc., currently not represented in visible numbers in cancer research, education
and clinical care delivery given the population of our catchment area in the Bronx, have the opportunity and are
supported to participate and be included in all aspects of our Cancer Center activities. We plan to achieve this
goal by establishing, sustaining, and continuously monitoring our investments in institutional infrastructure and
implementing programs to establish, promote, and sustain a culture of diversity, equity and inclusivity, increase
participation of women, racial/ethnic minorities, and other underrepresented groups in the cancer workforce and
in leadership through pipeline program with key stakeholders in the Bronx, and building, by strengthening and
evaluating the capacity of the workforce to integrate a culture of diversity, equity and inclusivity excellence in
research, clinical care delivery and community engagement. It is essential that an effective plan to enhance
diversity must be cross-cutting, and for this reason, we will synergistically coordinate all activities among other
components of the Cancer Center such as Community Outreach and Engagement (COE) and Cancer Research,
Training and Education Coordination (CRTEC) components, Cancer Epidemiology, Prevention and Control
Program, and the clinical services and clinical trials in support of our core mission and vision.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward PLAN TO ENHANCE DIVERSITY - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page